Administrative Core

Project Summary: Administrative Core
The Administrative Core for the Nebraska Center for Molecular Target Discovery and Development (CMTDD)
leads, implements, and supports the Center's primary activities. These activities include creation of critical
infrastructure for the (1) identification of disease targets, (2) generation of small molecules that manipulate those
targets, and (3) analysis of preclinical models in which to evaluate the manipulation of those targets. Creation of
that infrastructure facilitates the Center's effort to deliver training and mentoring to promising new investigators
focused on the discovery of new approaches that improve the treatment of disease. The Administrative Core
provides the organizational and programmatic leadership necessary to ensure the CMTDD works efficiently
toward attaining its goal and is responsive to emerging research opportunities that improve its effectiveness.
This effort includes continued implementation of Center-wide activities – including an annual retreat, monthly
meetings of the CMTDD membership, formal and informal training, and support for external seminar speakers –
to create a collaborative research environment, promote the CMTDD on a national level, and build a pool of
talented doctoral and postdoctoral students in the laboratories of Center members. The Administrative Core
coordinates a faculty development plan that includes a Research Project Program and Pilot Grant Program
designed to accelerate the transition of talented Research Project Leaders to independence and support the
development of multi-investigator grants and program projects. Finally, the Administrative Core serves as a
coordination point between CMTDD members and the Center's Scientific Cores. The Administrative Core
supports research programs and related scientific cores to develop innovative tools for the detection and
validation of molecular targets and provide guidance in experimental design and data analysis.